Contribution of Nutrient Delivery Rate to Gut-Brain Axis Signaling in Obesity and Bariatric Surgery

PROJECT SUMMARY/ABSTRACT
Mechanisms underlying sustained weight loss after bariatric surgery remain unclear, though rapid nutrient
delivery is a major candidate driving decreases in caloric intake via the gut-brain axis. Preclinical models have
demonstrated the importance of the gut-brain axis in modulating short- and long-term feeding and taste
preferences through gut-brain neural connections and the endocrine gut peptide response. Our clinical
preliminary data demonstrates that rapid intestinal nutrient infusion (bypassing the stomach) in non-surgical
patients with obesity can mimic the augmented gut-brain endocrine response (e.g. GLP-1) of bariatric surgery.
Our overarching hypothesis is that bariatric surgery induces a chronic state of rapid nutrient delivery leading to
hypersecretion of gut peptides known to signal satiety, slow GI motility, and decrease nutrient-rich food
preference. This sustained and altered enteral delivery modifies nutrient-stimulated, gut endocrine and gut-
brain signaling, which changes feeding behavior and leads to weight loss. In the following project, we will (Aim
1) test the hypothesis that rapid nutrient delivery is associated with augmented GLP-1 and brain fMRI
responses. Human subjects being evaluated for bariatric surgery will undergo non-invasive placement of an
enteral feeding tube for a variable rate glucose infusion into the small intestine, with concurrent measurement
of the rapid brain signaling response using functional magnetic resonance imaging (fMRI) and gut peptide
endocrine response. Additionally, we will (Aim 2) test the hypothesis that Roux-en-Y Gastric Bypass (RYGB) is
associated with faster nutrient absorption compared to Sleeve Gastrectomy (SG). Preoperative and
postoperative measurements of intestinal nutrient uptake will be made with non-metabolizable glucose and
amino acid tracers, with measurement of the corresponding gut peptide endocrine responses to understand
the putative differences in postoperative absorption of sleeve and gastric bypass. This career development
plan is highly innovative, combining enteral nutrient infusion with fMRI to begin to (1) establish rapid intestinal
nutrient delivery as a primary driver of the gut endocrine response of bariatric surgery, (2) determine the
degree to which the most common bariatric operations increase nutrient absorption, and (3) identify brain
regions that are rapidly responsive (within seconds) to enteral nutrient presence similar to preclinical rodent
studies. Understanding gut-brain axis physiology and how it is altered by bariatric surgery may lead to
identification of novel therapeutic strategies and simpler surgical or endoscopic treatments for obesity. The
training plan associated with this career development award allows the PI to gain the necessary training in
patient-oriented research and focuses long-term research efforts in studying the gut-brain axis in obesity and
bariatric surgery.

Public health relevance
PROJECT NARRATIVE Mechanisms driving weight loss after bariatric surgery remain unclear, though rapid delivery of nutrients mimics the augmented gut peptide response of bariatric surgery even in non-surgical patients. This career development award combines enteral nutrient infusion and tolerance testing with functional magnetic resonance imaging (fMRI) to (1) test the hypothesis that rapid nutrient delivery is associated with increased gut peptide and brain fMRI responses, (2) test the hypothesis that Roux-en-Y gastric bypass is associated with faster nutrient absorption compared to sleeve gastrectomy, and (3) identify brain regions rapidly responsive to enterally delivered nutrients.